EFFECTS OF INSULIN REDUCTION BY METFORMIN ON SEX STEROIDS IN BREAST CANCER

To determine whether reducing serum insulin levels in women with breast cancer by administration of metformin beneficially alters circulating sex steroid levels (i.e., lowers serum free estrogen concentrations).